Targeting the Default Mode Network: A TMS-fMRI Study

PROJECT SUMMARY / ABSTRACT
Post-traumatic stress disorder (PTSD) is a devastating illness in which traumatic autobiographical memories
are intrusive and lead to anxiety symptoms. These symptoms align with the functions of the default mode
network (DMN) and, in fact, PTSD patients have abnormalities within the DMN and in its interactions with other
networks, notably the salience network and the frontoparietal or central executive network. Focal repetitive
pulse transcranial magnetic stimulation (rTMS) enables neuromodulation of selected brain regions and
connected networks to treat specific symptoms, but the brain targets to support this therapy in PTSD are under
discovery. A recent analysis uncovered a brain circuit associated with improvement in anxiety and somatic
symptoms following the rTMS treatment of depression. The left hemisphere region with the strongest fMRI
functional connectivity with this circuit lies within anatomical area 8Av and the DMN. This association suggests
that modulating the DMN through stimulation at left 8Av could be a novel rTMS approach for the treatment of
anxiety and may help ameliorate anxiety symptoms in PTSD. This target would be novel since the vast majority
of clinical trials of rTMS in PTSD have targeted the right frontal regions of the salience and frontoparietal
networks instead of the DMN. One potential reason is that the most established nodes of the DMN do not lie
directly below the scalp/skull and are thus unreachable by rTMS. In this proposal we test the overall hypothesis
that left area 8Av can serve as a robust, direct brain target for the DMN thus facilitating therapy for PTSD and
the many other disorders involving the DMN. We propose to use TMS-fMRI in 30 Veterans with PTSD to test
the causal connections between left 8Av and other regions that could mediate a response. We will test the
connectivity between 8Av and the inferior parietal lobe (IPL), a region in the DMN involved in context
processing, and other nodes of the DMN (e.g., posterior cingulate, ventromedial prefrontal cortex). We have
pilot data in which we found the functional connection between 8Av and the IPL to be abnormal relative to
controls, and also that delivering rTMS to these regions ameliorates anxiety. We will also explore whether
stimulation at 8Av modulates the anterior insula, a node of the salience network whose functional connectivity
predicts benefit from prolonged exposure therapy in PTSD. We will measure the TMS induced BOLD response
in these areas to stimulation of 8Av and compare this response to conventional seed-based resting-state fMRI
functional connectivity analyses that could serve as an alternative marker for capacity for modulation. In
addition we will deliver thetaburst rTMS stimulation and study how connectivity changes with respect to
baseline. Our overall goal is to characterize left 8Av functional connectivity in PTSD, and explore the
effects of rTMS stimulation parameters. This project will thus provide a mechanistic understanding of
rTMS therapy at 8Av, and will reveal the effects of a novel connectivity-based atlas target.

Public health relevance
PROJECT NARRATIVE In post-traumatic stress disorder (PTSD), intrusive, traumatic, autobiographical memories lead to anxiety symptoms, and recent work suggests a novel repetitive pulse transcranial magnetic stimulation (rTMS) brain target that might bring relief. Since this proposed target is not well understood, our goal is to use functional magnetic resonance imaging (fMRI) to identify the brain regions and networks that change with rTMS stimulation at this target in PTSD patients. This project will help us understand how rTMS stimulation at the proposed target affects the brain, and will reveal the benefits of a personalized targeting.